Weathering the Storm of Cognitive Inequities: Testing the Minority Stress and Cognition Model with Indigenous Older Adults

Project Summary/Abstract
The number of Indigenous older adults (IOAs) in the United States, defined here as Native American and Alaska
Natives, will more than double in the next 30 years. Concurrently, the number of IOAs living with Alzheimer’s
Disease and Related Dementias (ADRDs) will also increase. Our limited knowledge about the cognitive health
of IOAs represents a crisis of health equity. This proposed study aims to not only shed new light on this issue,
but also to promote the equitable inclusion of IOAs in cognitive health research, policy, and intervention. This
proposed study is guided by a conceptual model that integrates these risk factors into a stress framework; the
Minority Stress and Cognition Model. This model posits that exposure to higher levels of psychosocial stress in
the form of individual (e.g. perceived racism) and systematic discrimination (e.g. low quality of education,
poverty) increase one’s susceptibility to chronic health conditions and the risk of cognitive impairment in later life
via an accumulation of allostatic load. This study extends this model to IOAs, a population of color that also
experienced systemic racism, poor educational quality, poverty, health inequities, and racism in the United
States. This proposal aims to address these knowledge gaps by using restricted Health and Retirement Study
(HRS) data to investigate how an understudied group of IOAs fared over a 10-year period (2008-2018) in the
domain of cognitive health. The specific aims of this proposed study are: 1) To investigate longitudinal
differences in cognitive health between Indigenous, Black, Hispanic, and White older adults; 2) To determine
how psychosocial factors are associated with total cognition trajectories among Indigenous, Black, Hispanic, and
White older adults; and 3) To determine how behavioral, and physical stress factors are associated with total
cognition trajectories among Indigenous, Black, Hispanic, and White older adults. I hypothesize that alongside
other risk factors for cognitive impairment (e.g. low levels of education, low SES, alcohol and cigarette use,
physical inactivity, high allostatic loads) higher levels of perceived discrimination will be associated with lower
overall total cognition trajectories and earlier onset of decline. Using restricted data from the Health and
Retirement Study Core sample and the 2008-2016 Leave-Behind Questionnaire, this proposed study will
investigate the change on a measure of total cognitive function (TICS-M). To do this, total cognitive function
trajectories will be fitted with sociodemographic information (age, gender, race/ethnicity) and then modified first
by psychosocial and then by physical, and behavioral factors. These relationships will be assessed using several
statistical methods: 1) descriptive statistics, 2) t-test and chi-squared statistics, 3) correlation coefficients, and 4)
mixed effect growth curve models. Missing data treatment will be conducted using Full Information Maximum
Likelihood estimation. This proposed study has important implications for stress and cognition models, the health
equity of Indigenous older adults, and future preventative research. This proposal is responsive to PAR-19-394:
Aging Research Dissertation Awards to Increase Diversity.

Public health relevance
Project Narrative This research contributes to novel information about the cognitive health of Indigenous older adults in the United States by reporting on data from the only available longitudinal, representative sample of this population. This research also tests the relationship between discriminatory stress experiences, allostatic load, and cognitive health by estimating total cognitive function trajectories for these older adults. This study enhances our knowledge about a historically underrepresented population in cognitive health research. .